Evaluation of Trigeminal Ganglia Sensory Neuronal Population/s Mediating MIF-Induced Anti-Nociception in a Model of Apical Periodontitis.

Abstract
Despite the success of root canal treatments at treating diseases such as apical periodontitis, 1.8 million patients
may experience persistent pain six months after treatment. Apical periodontitis is caused by an infection of the
dental pulp leading to mechanical allodynia and inflammation. Persistent dental pain increases cost of burden
and intake of analgesic drugs. Furthermore, non-steroidal anti-inflammatory drugs (NSAIDs) and opioids provide
incomplete pain relief and adverse effects when taken chronically, highlighting the need for a novel treatment
that can provide relief to millions of patients experiencing persistent dental pain. The study of stem cells for their
analgesic properties has been rapidly growing in hopes of developing a novel class of analgesics. The efficacy
of mesenchymal stem cells has been demonstrated in pre-clinical models of neuropathic pain and in patients
diagnosed with migraines and osteoarthritis. Preliminary data demonstrates that intravenous injections of human
stem cells of the apical papilla (hSCAP) fully reverses hypersensitivity associated with apical periodontitis in
mice. RNA sequencing of hSCAP homed to the infected tooth shows a 133-fold increase in the expression of
the cytokine Macrophage Migratory Inhibitory Factor (MIF). Additionally, MIF receptors CD74 and CXCR4
colocalize on TRPV1+ neurons in the trigeminal ganglia. Moreover, a local injection of recombinant MIF reverses
hypersensitivity associated with apical periodontitis. Lastly, conditioned media from co-cultures of mouse
periapical granulomas (the infected tooth) and hSCAP attenuates capsaicin evoked Ca2+ response from
trigeminal ganglia neurons and is inhibited with pre-treatment of a MIF antibody. This data supports a novel
mechanism for stem cell anti-nociception through the direct effect of stem cells that is possibly mediated by MIF.
However, despite primary data suggesting MIF directly inhibits trigeminal ganglia neuronal activity, the neuronal
subtypes that MIF-induced anti-nociception are unknown. The pain induced by apical periodontitis is often
reported as referred, suggesting the involvement of non-nociceptive fibers due to central sensitization.
Understanding which of these subpopulations mediate MIF-induced anti-nociception will allow us to develop
targeted treatments for persistent dental pain associated with apical periodontitis. We will test the central
hypothesis that MIF-induced inhibition of trigeminal ganglia neuronal activity is mediated by nociceptive and non-
nociceptive neurons. To test this hypothesis, we will 1) conduct single cell RT-PCR and immunohistochemistry
to determine co-expression of MIF receptors CD74 and CXCR4 with different neuronal markers and 2) use Cre-
recombinase to conditionally knockout MIF receptors CD74 and CXCR4 from specific neuronal populations in
vivo and evaluate their contributions to MIF anti-nociception in a model of apical periodontitis. These studies will
not only provide novel insight into the neuronal populations that mediate MIF-induced anti-nociception but also
serve as an excellent training vehicle for my career as a clinician-scientist.

Public health relevance
Narrative Persistent dental pain after treatment of apical periodontitis has a major clinical impact, however, currently available drugs have adverse effects, potential for physical dependency, and provide incomplete pain relief. We propose to study the neuronal subpopulation that stem cell released macrophage migratory inhibitory factors targets to mediate pain relief in a model of apical periodontitis. The proposed studies will advance the study of a targeted therapeutic to treat millions experiencing persistent dental pain.